Lakeside Conference on Protein Toxins and Effectors 2021

PROJECT SUMMARY/ABSTRACT
Protein toxins and effectors are primary virulence factors of many bacterial pathogens. They cause diseases by
targeting and disrupting key cellular functions. Historically, research on toxins/effectors has focused on only a
few major toxins, which has achieved tremendous successes in establishing the framework of their mechanisms
and in eradicating many devastating infectious diseases. Building on these earlier successes, the field has gone
through a great resurgence and expansion in the past 20 years, transforming from a narrow focus on a few
human diseases to much broader areas of biology, centering on understanding “protein-based” fight-and-
defense communications between co-evolving organisms. For instance, recent advances in microbial genomics
and discovery-based screening approaches have led to a dramatic increase in the number of toxins and effector
systems being studied. New research has also revealed that microbes secrete and inject toxins and effectors
not only to target eukaryotic cells during pathogenesis, but also to engage in interbacterial competition.
Technological advances in high-resolution microscopy, structural biology, cryo-electron microscopy, proteomics,
and CRISPR have rapidly advanced our understanding of toxins/effectors action. Despite the growth of both the
depth and breadth of the field, there is currently no meeting in North America centered on toxins/effectors that
can bring people together from diverse fields. To address this gap, we are launching a reconfigured and
reimagined “in person-virtual” hybrid conference, “Lakeside Conference on Protein Toxins and Effectors”
(#LakesidePTE) to be held October 3-6, 2021 at the Abbey Resort in Lake Geneva, Wisconsin, USA, leveraging
the participation and enthusiastic feedback received during our inaugural meeting in October 2020, which was
entirely on-line. This newly hybrid conference will focus on the cellular, structural, and biochemical mechanisms
of protein toxin and effector action and the translation of these proteins for treatment of human disease. The
conference will be organized by Chair Karla Satchell at Northwestern University and Vice-Chair Steven Blanke
at University of Illinois at Urbana-Champaign. A ten member scientific advisory board will assist in selection of
speakers and abstract review. There will be 5 sessions and three keynote addresses (Dr. Rod Welch from
University of Wisconsin; Dr. Theresa Koehler from University of Texas-Houston, and Dr. Craig Roy from Yale
University). Ten additional invited speakers will anchor five scientific sessions that will be filled out with talks
selected from abstracts. Here we are seeking NIAID funds 1) to support registration fee and travel for keynote
and invited speakers, (2) to offer registration scholarship awards for underrepresented minority post-docs and
graduate students and (3) for audiovisual support for a hybrid meeting that will be simultaneously live streamed.
This support from NIAID will bring together microbiologists, biochemists, structural biologists, and biophysicists
to encourage new collaborations across disease and phylogenetic boundaries and test an innovative model for
the future of this conference as a hybrid conference that will reach a global audience.

Public health relevance
PROJECT NARRATIVE This application requests funding for a conference, “Lakeside Conference on Protein Toxins and Effectors”, to be held October 3-6, 2021 in Lake Geneva, Wisconsin, USA. This scientific conference will focus on the cellular, structural, and biochemical mechanisms of protein toxins and effectors action and the translation of these proteins for treatment of disease. The goal of the conference is to bring together this community of microbiologists, biochemists, structural biologists, and biophysicist and encourage new collaborations across disease and phylogenetic boundaries and to educate trainees. Importantly, this “in person-virtual” hybrid conference is being launched with the intention of promoting both diversity and the highest level of inclusion for scientists and their laboratory teams who are unable to attend the meeting in person.